Towards Glucose Transporter-Mediated Glucose-Responsive Insulin Delivery with Fast Response

PROJECT SUMMARY
Glucose-responsive delivery of insulin mimicking the function of pancreatic β-cells to achieve meticulous
control of blood glucose (BG) would revolutionize type 1 and advanced type 2 diabetes care. However, it is
extremely challenging to demonstrate a system which would combine fast response, reversible activation,
ease of administration and excellent biocompatibility. In this proposal, we aim to establish an innovative
glucose-responsive insulin delivery system based on the interaction between the glucose derivative-
modified insulin (Glu-insulin) and glucose transporters (GLUTs) on red blood cells (RBCs). This binding
interaction is reversible in the setting of hyperglycemia, resulting in fast release of insulin and subsequent
drop of blood glucose levels. We will exploit two conjugation formulations of Glu-insulin and glucose
transporters (GIGTer): 1) polymeric nanoparticles (NPs; ~100 nm in diameter) coated with the RBC
membrane (with GLUTs) and loaded with Glu-insulin; and 2) liposomal NPs integrated with exogenously
expressed glucose transporters and Glu-insulin. We will further integrate these two glucose-responsive
formulations into a painless microneedle (MN)-array based transcutaneous patch to obtain the “smart
insulin patch” (SIP). Glu-insulin encapsulated NPs will also be incorporated inside SIP for serving as insulin
reservoir to “recharge” GIGTers for up to 48 h regulation within a normoglycemic range. In vivo potency of
smart insulin patch will be evaluated using the streptozotocin (STZ)-induced type 1 diabetic male C57B6
mice and Sprague Dawley rats. In Aim 1, we will validate and optimize the glucose-responsive capability of
the GIGTers based on our preliminary study. In Aim 2, we will evaluate the effectiveness of SIPs integrated
with GIGTers, determining the feasibility of utilizing the GIGTer as a new administration modality. In Aim 3,
we will optimize the physicochemical properties of the GIGTer-integrated patches in type 1 diabetic mouse
and rat (implanted with the Continuous Glucose Monitoring System, CGMS) models; we will substantiate
the glucose-responsive capability as well as the biocompatibility of SIPs with GIGTers. The proposed goal,
when successfully realized, will be a significant upgrade over the current insulin-dependent diabetes
therapy options and have a profound impact to improve health and quality of life of diabetic patients.

Public health relevance
RELEVANCE TO PUBLIC HEALTH A glucose-responsive “closed-loop” insulin delivery system mimicking the function of pancreatic cells has tremendous potential to improve health and quality of life of type 1 and advanced type 2 diabetic patients. In this proposal, the PI intends to establish an innovative glucose-responsive insulin delivery mechanism and develop relevant formulations and devices, which are based on the interaction between the glucose derivative-modified insulin and glucose transporters. The proposed goal, when successfully realized, will be a significant upgrade over the current insulin-dependent diabetes therapy options.